Multidisciplinary Research Training to Reduce Inequalities in Cardiovascular Health

Project Summary
This is an application for the first five-year renewal (years 6-10) of the Multidisciplinary Research Training to
Reduce Inequalities in Cardiovascular Health (METRIC) T32 for predoctoral and postdoctoral fellows at Emory
University. The goal of the METRIC T32 program is to train diverse candidates in the study of cardiovascular
health inequalities broadly defined, based on factors such as race/ethnicity, sex/gender, socioeconomic status,
geographical residence, healthcare access, and physical/mental disability, with a focus on the underlying
biological, behavioral and environmental mechanisms. A distinguishing feature of our program is the utilization
of a multidisciplinary approach to expose trainees to multiple methods and research areas, from epidemiology
and biostatistics to behavioral and social sciences, biological sciences, and health policy and implementation.
Each trainee has a primary mentor but works within a mentoring team with diverse expertise. A maximum of 5
predoctoral and 5 postdoctoral trainees will be in the program at any time point, each supported for an average
of 3 years for predocs and 2 years for postdocs. Training will include multidisciplinary mentoring along with
coursework, inter-departmental seminars, hands-on research, grant writing and career development. Our main
source of predoctoral applicants will continue to be PhD students entering the School of Public Health's
doctoral programs. Postdoctoral fellows will be MDs pursuing a research career in cardiovascular disease, or
PhD graduates in epidemiology, nutrition, behavioral sciences, environmental sciences, health policy, or other
relevant areas. Postdoctoral trainees will have the opportunity to obtain a MS in Clinical Research. In the past
funding cycle all our training slots were filled, and we have utilized three supplementary diversity slots. The
program shows a strong track record for successful training and career development, promoted by solid
collaborations among the Rollins School of Public Health, the School of Medicine, the School of Nursing, and
the Morehouse School of Medicine. Of all the fellows appointed, 50% are from underrepresented racial/ethnic
minority groups. Our program responds to several emphasis areas for NHLBI T32 programs, including
multidisciplinary training, collaborative research, diversity of trainees, quantitative sciences, and translation
research, with strong emphasis on mentorship and career development. Addressing cardiovascular health
inequities is a top priority of the strategic vision of the NHLBI's Division of Cardiovascular Sciences. The
ultimate goal of this program is to prepare diverse individuals for leadership positions in biomedical and health
care research in order to build capacity for research and translation to reduce inequalities in health and health
care for cardiovascular disease.

Public health relevance
Project Narrative Inequalities in cardiovascular health are a pervasive problem that has remained essentially unchanged over the past several decades in the United States. This T32 competing continuation application proposes to train the next generation of leading researchers to pioneer innovative research using a multidisciplinary approach in order to reduce cardiovascular health disparities.